Investigating the Role of Protease-mediated signaling in M. tuberculosis Virulence

TITLE
Investigating the Role of Protease-mediated signaling in M. tuberculosis Virulence
ABSTRACT
The bacterium M. tuberculosis (Mtb ) persists as a threat to human health, with tuberculosis (TB)
killing an estimated 1-2 million people annually. Unfortunately, a molecular understanding of how
Mtb evades the immune system is lacking. This critical gap in knowledge slows the design of new
therapies that seek to improve TB vaccine efficacy or to promote sterilizing immunity in TB patients.
My hypothesis is that when Mtb infects a host macrophage, it deploys proteases to degrade
proteins involved in the immune response. I propose to explore the hypothesis that secreted Mtb
proteases contribute to virulence by cleaving host proteins. We will use a unique combination of
proteomics methods to 1) identify potential targets of secreted Mtb proteases, and to 2) globally
profile proteolysis events during Mtb infection. I will then use genetic analysis in both M.
tuberculosis and the host to disrupt both the bacterial proteases and their putative host substrates
to evaluate the role that proteolysis plays in TB pathogenesis.

Public health relevance
PROJECT NARRATIVE This project is relevant to human health because understanding how Mycobacterium tuberculosis disrupts the immune system will help lay the foundation for developing future therapies aimed at restoring immune function and thereby improving therapy for tuberculosis.